The Influence of Sedentary vs. Active Lifestyles on Chondrocyte Homeostasis and Cartilage Health: A Novel Benchtop Explant Study

Project Summary
Contemporary evidence highlights a doubling of osteoarthritis (OA) prevalence in the post-industrial era;
suggesting that OA might represent a ‘mismatch disease’. It has been suggested that the ‘mismatch’ underlying
OA is our increasingly sedentary and inactive modern lifestyle. While mythos has led some to believe that
physical activity endangers joint health, reality is far different; moderately- to highly-active individuals experience
no increase in OA risk, but instead prolonged joint health. Conversely, increased sedentary inactivity appears
associated with OA risk. However, the biomechanical, cellular, and molecular mechanisms underlying the
differential effects of activity on cartilage health remain largely unresolved; partly due a lack of tools for studying
these phenomena under well-controlled and physiologically-consistent sliding environments ex vivo. Recently,
our team has leveraged a long-forgotten bench-top cartilage testing configuration, the convergent stationary
contact area (cSCA), to fundamentally transform our understanding of how articular cartilage biomechanics (i.e.
deformation & hydration) and tribology (i.e. lubrication and wear resistance) are enhanced by activity and
compromised by inactivity. This unique tool represents the first (and only) explant testing platform to allow
precisely controlled operation under truly physiologically conditions (high applied stresses, interstitial pressures,
& sliding speeds; and moderate strains, & low friction/shears) for biologically relevant durations (hours to days).
Moreover, the ability to easily model ‘daily’ joint activities via the cSCA has allowed us to use this platform to
demonstrate how increasing activity frequency and decreasing continuous sedentary bout length
tribomechanically benefits cartilage by preventing load-induced tissue strain and loss of hydration, thereby
buffering against wear inducing friction. Combining our recent cSCA-derived understanding of cartilage
tribomechanics with established studies linking losses of interstitial pressure and lubrication to chondrocyte
dysfunction and tissue catabolism, we posit that activity-modulated recovery of tissue hydration is a critical and
under-recognized regulator of cartilage tribomechanics, chondrocyte homeostasis, and joint health, and that
modern, post-industrial increases in OA prevalence likely reflect simple mechanobiological consequences of
chronic prolonged inactivity compromising the functional competency of cartilage. The goal of this proposal is to
leverage the unique physiological relevance, experimental precision, and cellular interrogation capabilities of the
cSCA platform to i) establish critical predictive relationships between activity volume, activity frequency,
cartilage’s sliding biomechanics, and in situ chondrocyte homeostasis and ii) Identify how cartilage injury alters
the relationships between activity, sliding biomechanics, and in situ chondrocyte homeostasis. The findings from
this research will generate new knowledge regarding the basic mechanobiological function of articular cartilage
and will help to inform rationally based and mechanistically grounded activity prescriptions for promoting and
maintaining cartilage and joint longevity in healthy and injured joints.